Conditional mouse models with dominant negative Osteogenesis Imperfecta

The goal of this R21 application is to convert existing mouse models of moderate and severe Osteogenesis
Imperfecta (OI) caused by type 1 collagen mutations to conditional mouse models of moderate and severe OI.
Conditional mouse models offer several advantages over the existing strains. First, conditional mouse strains
can be maintained and distributed by public repositories; existing strains are in individual labs, and not in
repositories, because of their skeletal fragility. Second, OI is a multi-system disease that affects bone, heart,
lung, tendon, ligament, and skin. When studying OI, the phenotype in one organ system (e.g., heart or lung) is
confounded by disease-associated problems in another organ system (e.g., spine and ribs). Conditional mouse
models in which Cre-recombinase is used to express the mutant protein in a tissue-specific manner minimizes
this confounding. Currently, there are no conditional mouse models with type 1 collagen mutations, even
though ~ 85% of human OI is caused by such mutations. Third, by converting existing strains to conditional
strains, any new data obtained with the conditional strains can be compared to previously published data
because the same mutation was studied. We will modify existing alleles by inserting a gene-trap using i-
GONAD gene-editing technology. Applying gene-traps and i-GONAD will enable us to efficiently convert 4
existing OI-causing alleles (Aga2, Jrt, Brtl, and p.G610C) in mice to conditional OI-causing alleles. Mouse
strains with the new conditional alleles can be distributed by public repositories. We will also determine the
effect of inducing endogenous expression of mutant type 1 collagen in hypertrophic chondrocytes, since
hypertrophic chondrocytes have been shown to transdifferentiate into osteoblasts and osteoprogenitors.
Therefore, it is important to know if bone properties are strongly influenced by cells expressing mutant type 1
collagen that have descended from hypertrophic chondrocytes, or if unaffected bone forming cells descended
from other progenitor sources compensate for, or outcompete, the mutant hypertrophic chondrocyte-derived
descendants. This latter knowledge will aid investigators who are interested in using cell therapies to
displace/replace mutant osteoblasts and osteoprogenitors with wild-type ones.

Public health relevance
We will use the gene-editing technique i-GONAD to insert gene-traps into 4 different mouse models of moderate and severe OI. This enables public repositories to distribute the mice and investigators to study tissue-specific effects of inducing endogenous levels of mutant type 1 collagen expression after Cre- recombination. We will study the effect of inducing mutant type 1 collagen expression in hypertrophic chondrocytes and their descendants.